Identification of a Putative Mitochondrial Solute Carrier that Regulates Mitophagy

ABSTRACT
Mitochondria are essential for cell health and survival. Understanding the quality control machinery that
mitochondria employ to maintain a healthy network is critical for health and disease. Our lab recently showed
the role that lipid transfer protein Vps13D plays a critical role in mitochondrial clearance by autophagy (mitophagy)
in the Drosophila developing midgut. Vps13D has been implicated in human movement disorders, highlighting
the importance of understanding how it controls this process. Importantly, we do not know what proteins Vps13D
may be interacting with at the mitochondrial surface to facilitate mitophagy. I performed an RNAi screen against
mitochondrial genes that were shown to physically interact with Vps13D in human cells. I discovered that Mtch,
the fly homolog of MTCH2, phenocopies both mitochondrial and autophagic defects that Vps13D mutants display,
including failure to clear mitochondria, autophagic cargoes like p62, and the autophagy protein Atg8a. I
generated a null mutant for Mtch, which displays phenotypes similar to what is observed by Mtch knockdown
with RNAi and Vps13D mutants. Importantly, Mtch mutant cells exhibit a robust decrease in Vps13D protein
puncta. I plan to use this Mtch mutant to: (1) characterize the function of Mtch in mitophagy, (2) determine the
relationship between Mtch and Vps13D in mitophagy, and (3) investigate the relationship between Mtch and
known regulators of autophagy and mitophagy. These studies will advance the field by creating a better
understanding of mitophagy, and will also provide a novel genetic pathway to study that could lead to targeted
therapies to correct mitochondrial disorders.

Public health relevance
Project Narrative Mitochondrial-selective autophagy (mitophagy) is an essential cellular process needed to promote cell survival, but the genes that play a role in this process are not well understood. I am studying a novel regulator of mitophagy at the mitochondrial surface that physically interacts with lipid transport protein VPS13D, a gene implicated in age-associated movement disorders that regulates mitochondrial clearance. Studying this process will benefit our overall understanding of mitophagy, and provide novel insight into therapeutics to combat defective mitophagy diseases like Parkinson’s disease.